Technology Training and Dissemination

TRAINING AND DISSEMINATION: PROJECT SUMMARY
The goal of the center is to improve the reproducibility and credibility of biomedical modeling. This requires
promoting the importance of reproducible and credible modeling, advertising the center's capabilities,
distributing the center's tools, and assisting and training the modeling community.
Technology integration. To make it easy for researchers to build and assess credible models, the core will
(1) test and provide the TR&Ds feedback on the usability of their software tools and (2) and integrate their
software tools into seamless reproducible modeling workflows.
Dissemination. The core will coordinate several activities to promote the importance of reproducible
modeling, advertise the center's and others' modeling tools, and distribute the center's tools. This will include
organizing meetings to discuss developments in standards and other reproducibility technologies, organizing
two day competitions to distill best practices from the community, publishing the center's technologies,
publishing a website and newsletter to advertise the center's and others' modeling tools, contributing articles to
community newsletters and journals on credible modeling, publishing a website to advertise the center's
services and recruit new collaborative and service projects, and overseeing the documentation and distribution
of the center's tools. This will include efforts to promote reproducible modeling across multiple modeling fields
such as systems biology, neurophysiology, multiscale modeling, biomechanics, and physiology.
Training. The core will coordinate several activities to train researchers how to conduct credible modeling.
This will include organizing two summer schools, presenting tutorials at conferences, and developing online
training videos. The core will also solicit feedback on the center's training activities to help improve these
Activities.
Service coordination. To ensure the center's collaborative and service projects are effective, the core will
manage a ticketing system for new collaborative and service project requests, use surveys to solicit feedback
from the collaborative and service project clients, use the competitions to advertise and recruit new
collaborators and service users, and provide this feedback to the TR&Ds to help them improve their services.
Management plan. The core will coordinate the center's training and dissemination activities by organizing
monthly meetings with all of the center's key personnel. The Training and Dissemination Core will be overseen
by the Executive Committee.